Core B: Biostatistics and Computational Biology Core

CORE B- BIOSTATISTICS AND COMPUTATIONAL BIOLOGY CORE
PROJECT SUMMARY
The Dana-Farber/Harvard Cancer Center Specialized Program of Research Excellence in Breast Cancer
(DF/HCC SPORE in Breast Cancer) Biostatistics and Computational Biology Core (Core B) collaborates with
and provides consultation on all research activities within the SPORE, including SPORE Projects, Developmental
Research and Career Enhancement Projects, and other SPORE Cores, to ensure the highest standards of
scientific rigor in areas of study design, data management and integrity, and data analysis and interpretation.
The overarching goal of the SPORE is to promote translational research derived from fundamental discoveries
in the laboratory that can lead to tangible clinical benefit. To this end, the Biostatistics and Computational Biology
Core will collaborate with other Cores to create an integrated system of resource support for the SPORE. The
Breast Cancer Biostatistics and Computational Biology Core has a wealth of experienced biostatisticians
equipped with excellent computational support, including major commercial and public-use statistical software,
and a large library of locally written software for design and analysis. The Core will leverage the computational
biology and bioinformatic expertise within the Projects and across DF/HCC resources and ensure conceptual,
data management and analytic integration across the Projects and Cores. Organizing biostatistical expertise as
a shared resource core, with effective integration of computational biology expertise, is a cost-effective approach
to ensure that collaboration is readily available to SPORE investigators and to promote the highest standards of
translational research.